Composition, Atomic Structure and Function of the Francisella Type 6 Secretion System, a Distinct Subtype Essential for Phagosomal Escape, Intracellular Replication, and Virulence

Project Summary/Abstract
Francisella tularensis is a bacterium that causes tularemia, a disease which, when in its pneumonic form, can
be fatal even with appropriate treatment. Due to its low infectious dose, ease of spread by aerosol, and high
virulence, F. tularensis is classified as a Tier 1 Select Agent by the U.S. federal government. This R01 project
builds on our earlier identification (by contact PI Horwitz's group) of the Francisella Type VI Secretion System
(T6SS) and our subsequent determination (by Horwitz's and MPI Zhou's group) of the first atomic models of its
sheath and its uniquely endowed central spike complex through cryo electron microscopy (cryoEM). T6SSs are
large, complex, multi-protein nanomachines that Gram-negative bacteria use to sense environmental cues and
deliver toxins into other bacteria or into eukaryotic hosts; in Francisella, they mediate phagosome escape and
intracytoplasmic replication. They are important virulence determinants, present in 25% of Gram-negative
bacteria and in an even higher percentage of those that are human pathogens. However, without knowing
T6SS composition and structure, we cannot fully understand its mechanisms of pathogenesis nor effectively
design countermeasures against a myriad of bacterial diseases. The T6SS of Francisella is both significant
and attractive to study because of the high infectivity and lethality of Francisella species and its relative
simplicity compared with other T6SSs. However, significant knowledge gaps remain, including the following:
(1) an atomic model of the structure of the pre-contraction outer sheath; (2) the composition and an atomic
model of the baseplate and membrane complex; and (3) the composition of the Francisella central spike and
secreted effector protein complex and an atomic model of its interaction with the sheath, baseplate, and
membrane complex in the pre-contraction state and during the contraction process.
To fill these gaps, we propose to carry out three major structure-function studies on T6SS using
Francisella novicida [and its closely related F. tularensis live vaccine strain (LVS)] as a model. First, we shall
obtain the atomic model of the sheath and tube complex in purified T6SS in its pre-contraction state with
cryoEM, and elucidate the energetics and mechanism of T6SS contraction by structural comparison with the
contracted sheath and structure-guided mutagenesis. Second, using proximity labeling, crosslinking, affinity
pull-down, immunoblotting, proteomics, and bacterial 2-hybrid analyses, we shall determine the composition
and protein interactions of the baseplate and membrane core complex. This information will be used in
conjunction with cryo electron tomography of T6SS-containing mini-cells to determine the composition and
structure of the T6SS baseplate and membrane complex in their pre- and post-contraction states. Third, we
shall determine the composition and structure of the Francisella T6SS central spike and secreted effector
complex. The results will form the foundation for future function studies and the development of new strategies
for treating and preventing diseases caused by the numerous important pathogenic bacteria that have a T6SS.

Public health relevance
Project Narrative Type VI Secretion Systems (T6SS) are macromolecular nanomachines and important virulence determinants present in one-quarter of Gram-negative bacteria, including many that cause serious human diseases, and thus, they are an important new target for strategies to combat infections caused by the bacterial pathogens that use them. However, to develop these strategies, we must better understand the composition, structure, and function of the T6SS. This proposal seeks to fill the gaps in our understanding of the T6SS in Francisella, which is classified as a Tier 1 Select Agent and requires the T6SS for its extremely high infectivity and pathogenicity.